University of Colorado Population Center

PROJECT SUMMARY
In response to RFA-HD-20-015 for the Population Dynamics Research Infrastructure Program
FY 2020 (P2C), the University of Colorado Population Center (CUPC) requests renewal of
infrastructure support for the five- year project period 2020–2025. With strategic investment of
15 years of center support from NICHD, CUPC has become a leading research institution in
several areas of population science that include health disparities and behaviors, reproductive
health, demography and genetics, migration and population distribution, and environmental
demography. CUPC was an innovative leader in the emergence of demography and genetics,
as well as environmental demography, as important areas of population science. It has gained
substantial momentum over the past five years, and exciting new collaborative possibilities have
emerged including ties with the University of Colorado’s (CU) Natural Hazards Center and new
Earth Lab. NICHD support has also been leveraged to garner generous new investments from
CU Boulder, and an agreement with CU Denver further solidifies CUPC as the hub of population
science along the Front Range. Three specific aims guide the Center’s activities in the next five
years: to (1) accelerate population science that matters; (2) fuel innovation in population
science; and (3) continue and increase support for junior scientists. To reach these aims, we
propose two cores. The Administrative Core maximizes affiliates’ research time by reducing
administrative burdens as well as by providing experienced, specialized assistance with grant
preparation and submission. The Development Core undertakes a wide variety of activities to
facilitate innovative scholarship, including offering a seed grant program, strong mentoring,
working groups, speaker series, mini-conferences, and workshops. Important changes have
been made in response to past successes, lessons learned, and new research opportunities.
These changes include higher limits for seed funding, an annual grant writing workshop, and
restructuring the center’s research leadership to further energize working groups and increase
faculty leadership opportunities. Overall, the proposal outlines a research plan firmly grounded
on a strong intellectual foundation that includes energetic new affiliates, several areas of high-
impact emerging scholarship, and new commitments from home institutions. The next five years
will build on CUPC’s critical momentum.

Public health relevance
PROJECT NARRATIVE The proposed award for research infrastructure at the University of Colorado Population Center will support population science that contributes important insights of relevance to public health. Central research topics include variation in health across sociodemographic groups, reproductive health, links between genetics or the environment and population health, and migration. Findings from research supported by this award inform public health policies and programs.